Neuronal mechanisms of novelty seeking

PROJECT SUMMARY
Behavioral experiments in humans and primates show that novel visual objects motivate behavior, by capturing
attention and gaze, and promoting learning. Abnormalities in novelty seeking are associated with obsessive
compulsive disorder, anxiety, depression, anhedonia and autism. But despite the importance of novel objects in
our daily life, and the clinical relevance of novelty seeking, we lack an understanding of how primate brain circuits
determine whether an object is novel, and how novelty signals control novelty-seeking. Previous studies reported
that neurons in many brain areas respond differently to novel stimuli versus familiar stimuli. However, novel
stimuli differ from familiar stimuli in many respects. For instance, novel stimuli are unexpected, deviate from
recent experiences, and motivate behavior. Such broad and diverse impact of novelty on behavior not only
highlights that it is critical to understand the neural mechanisms of novelty seeking, but also illustrates why it has
been challenging to dissociate novelty signals from other types of neural signals, and therefore why it has been
difficult to isolate how circuits utilize novelty to control motivated behavior. The hypotheses of the Aims are that
(i) object novelty controls novelty seeking through a newly discovered anterior ventral medial temporal cortex
(AVMTC) to zona incerta circuit, and (ii) single AVMTC neurons acquire novelty selectivity through a
quantitatively definable algorithm that considers object recency and object unexpectedness to mediate novelty-
related behaviors. Aim 1 will uncover the neural mechanisms that control motivated behavior to explore novel
objects. We devised a new behavioral paradigm that measures monkeys’ eagerness to experience novel objects.
Preliminary neurophysiological and causal experiments suggest that an understudied subthalamic region, the
zona incerta (ZI), controls the motivation to seek and explore novel visual objects, and that this ZI function is
distinct from other types of primary reward- and intrinsic- motivated behaviors, such as from the drive to obtain
information about uncertain rewards. These assertions will be fully tested by contrasting the novelty functions of
ZI with the habenula-dopamine pathway. We will also study how this circuit controls novelty seeking when novelty
has extrinsic values (e.g., good or bad) and must be integrated into object valuation. Aim 2 will determine the
mechanisms through which novelty responses arise in a wide range of primate brain circuits by recording single
neurons’ activity across temporal cortex, amygdala, hippocampus, and the prefrontal cortices with semi chronic
high channel count arrays while monkeys participate in a behavioral procedure that will (i) assess the
underpinnings of single neurons’ object novelty responses, and will (ii) dissociate novelty responses from signed
and unsigned subjective-value and prediction errors. These Aims offer an unprecedented opportunity to
understand how the brain mediates the curiosity to approach and explore novel objects, which is a fundamental
form of intrinsic motivated behavior that is particularly prominent in primates, and that is dysregulated in many
disorders of cognition and mood.

Public health relevance
PROJECT NARRATIVE Behavioral experiments in humans and primates show that novel visual objects motivate behavior by capturing attention and gaze, and promoting the formation of new memories. Abnormalities in novelty seeking are associated with anxiety, depression, anhedonia and autism, but despite the importance of novel objects in our daily life, and the clinical relevance of novelty seeking, we lack an understanding of how primate brain circuits control novelty related behaviors. Our experiments will reveal the neuronal mechanisms of novelty seeking in non-human primates – a fundamental form of motivation that is uniquely dysregulated in many disorders of cognition and mood.